Influence of DNA methylation changes on gene expression from the inactive X chromosome in B cells

Project Abstract
80% of patients afflicted with autoimmune diseases are female, and most autoimmune diseases have no cure.
Patients with female-biased autoimmune diseases such as systemic lupus erythematosus (SLE) aberrantly
express X-linked genes, suggesting that impairments in X chromosome inactivation (XCI) may impact disease.
XCI transcriptionally silences one X chromosome in XX females via enrichment of repressive epigenetic marks
including Xist RNA, heterochromatic histone marks, and DNA methylation (DNAm) to equalize X-linked gene
expression to XY males. While in vitro stimulated B cells exhibit association of all these repressive epigenetic
marks to the Xi, our laboratory found that Xist RNA and heterochromatic histone modifications are delocalized
from the Xi in naïve B cells. Preliminary allele-specific RNA-seq data indicate that majority of the inactive X
remains ‘continuously silent’ in naïve and stimulated cells, indicating that the inactive X in B cells remains silent
even in the absence of Xist RNA and heterochromatic marks. This suggests the existence of Xist RNA
independent mechanisms regulating Xi-linked gene expression in female B cells. Allele-specific RNA-seq data
reveal that of the 42 genes which are expressed from the inactive X in naïve cells, some are ‘continuously
expressed’ in stimulated cells. In addition, some genes become ‘newly silent’ or ‘newly expressed’ in stimulated
cells. Allele-specific whole genome bisulfite sequencing (WGBS) data indicate that the Xi remains highly
enriched for DNAm compared to the active X and autosomes in both naïve and stimulated cells, indicating that
it may be responsible for regulating gene expression from the inactive X independently of Xist RNA. As the
conversion of repressive 5’-methylcytosine (5mC) to 5’-hydroxymethylcytosine (5hmC) associates with gene
expression and WGBS alone does not differentiate them, I distinguished between these two forms of DNAm
using the novel technique bisulfite-assisted APOEBEC-coupled epigenetic sequencing (bACE-seq) alongside
WGBS. My preliminary data indicate that 5hmC is present at CpG dinucleotides within promoters of some
expressed X-linked genes, and that B cell stimulation alters its enrichment levels. DNA methyltransferases
(DNMT) deposit 5mC, whereas Ten Eleven Translocation (TET) enzymes remove it by generating 5hmC. I will
test my central hypothesis that DNMT and TET enzymes regulate gene expression from the inactive X in
stimulated B cells in an Xist RNA-independent manner. In Aim 1, I will perturb DNMT1 (Aim 1a), the DNMT
responsible for 5mC maintenance during cell replication, and DNMT3a/3b (Aim 1b), the DNMTs responsible for
novel deposition of 5mC, and assess the impact on 5mC enrichment and gene expression from the Xi. In Aim
2a, I will perturb TET2/3, the most highly expressed TETs in B cells, and assess the impact of perturbed 5hmC
enrichment on Xi-linked gene expression. In Aim 2b, I will perturb Xist RNA expression and assess whether
DNAm modulates Xi-linked gene expression independently of Xist RNA. Elucidating this mechanism will reveal
how X-linked gene expression can become perturbed in female-biased autoimmune diseases.

Public health relevance
Project Narrative Several autoimmune diseases exhibit a strong female bias, but the mechanisms underlying this bias are poorly understood. Altered X-linked gene expression in female-biased autoimmune disease patient lymphocytes suggests gene expression from the inactive X in female cells may be dysregulated. This project aims to investigate how changes in DNA methylation, which is globally dysregulated in patient cells, impact gene expression from the inactive X chromosome in B cells, and whether DNA methylation regulates gene expression independently of Xist, the long non-coding RNA responsible for X chromosome inactivation.